The NFkB System in Dendritic Cells

Project Summary/Abstract Dendritic cells (DCs) play key roles in targeting immune responses to pathogens, both by functioning as antigen presenting cells and by secreting potent innate immune and inflammatory cytokines. They differentiate from hematopoietic stem cells found in the bone marrow into multiple subtypes that have more inflammatory/adaptive immune or more innate immune functions. Misregulation of these differentiation processes is the root cause of myeloproliferative disorders (MPD) including acute myeloid leukemia (AML), and the inflammatory disease Langerhans Cell Histiocytosis (LCH). These differentiation processes may be recapitulated ex vivo with key myeloid differentiation and growth factors GM-CSF and Flt3L, and prior work has shown that the NFκB signaling system is an important regulator. Yet given the complexity of this multi- transcription factor, multi-regulator signaling system, its roles in subtype-differentiation, proliferation, and in disease remain poorly understood. In the proposed project we will examine the role of NFκB control in coordinating differentiation programs of dendritic cells into two developmental pathways. Based on our preliminary results we propose the overarching hypothesis that proper stepwise assembly of the NFκB signaling system during DC differentiation pathways is critical for phasing proliferation and maturation; while classical IκBα, -β, -ε mediate transient NFκB inflammatory responses, the recently described IκBsome plays a critical buffering and coordinating role in DC differentiation. Misregulation of the IκBsome leads to severe but surprisingly different phenotypes in the two DC developmental pathways. We will combine an experimentally validated mathematical model of NFκB signaling during dendritic cell differentiation and function, with quantitative biochemical, flow cytometric, and live cell fluorescence microscopy, interferometry and lineage tracking studies involving knockin reporter mice, and a number of novel genetic mouse strains to uncover the molecular basis of NFκB misregulation associated with myeloprolferative disorders (MPD) and Langerhans Cell Histiocytosis (LCH). We will apply these insights about the IκBsome regulation to examine patient samples and the efficacy and risks of potential drug targets.

Public health relevance
Project Narrative When the differentiation pathway of dendritic cells (DCs) – key regulators of human immune responses – is misregulated, a number of human ailments such as myeloid proliferative disorders, cancers, or inflammatory disease may result. In this project we will examine – at single cell resolution – how the NFB signaling system regulates proper phasing of proliferation and differentiation processes in two major DC lineages. The proposed studies involve novel animal, cell culture, and mathematical models and aim to understand the regulatory mechanisms that underlie two human diseases, acute myeloid leukemia (AML) and Langerhans Cell Histiocytosis (LCH).